Dissecting distinct contributions of different Prefrontal subregions on goal-directed visual attention

Visual attention is our ability to prioritize vision as a sensory modality, and our ability to extract discrete
information from a visual scene. The prefrontal cortex (PFC) is considered a source of feedback modulation to
the visual cortex– guiding, biasing or modulating activity in the visual cortex, to produce visual attention. The
visual cortex of the mouse receives monosynaptic input from two discrete PFC subregions, the anterior cingulate
cortex (ACA) and the orbitofrontal cortex (ORB), that contribute to diverse aspects of cognition. However, it is
currently unknown how these distinct PFC subregions contribute to different aspects of visual attention. Equipped
with precise understanding of distinct forms of PFC feedback modulation on visual processing, we will be in a
better position to strategically intervene in disorders of visual processing and attention. The proposed work
therefore aims to bridge the long-standing hypothesis of PFC feedback modulation with changes in population
activity in the visual cortex, how this activity change alters visual processing, and ultimately what effect this has
on goal-directed visual attention. To achieve this goal, I will quantitively and qualitatively compare the activity of
ACA and ORB axons in the visual cortex during different behavioral epochs of visual attention (Aim 1), probing
each areas contribution to different aspects of vision. In following, perturbating the activity of each discrete PFC
output pathway, allows me to observe changes in population activity in the visual cortex, how this activity change
alters visual processing, and ultimately what effect this has on goal-directed visual attention (Aim 2). Finally, I
will target PFC output pathways with a distinct connectivity profile, to understand how these projections modulate
the activity of the visual cortex, and if they represent a distinct functional module in regulating sensory processing
(Aim 3). Understanding how discrete subregions of the PFC influence the activity of the visual cortex, and its
behavioral consequences, will provide key insights towards the cellular underpinnings of visual processing in the
brain.
The proposed work will be conducted at the Brain and Cognitive Sciences Department, MIT, with the direct
mentorship of Prof. Mriganka Sur (MIT), from which I have already benefitted experimental training in numerous
techniques including two-photon microscopy, visual cortex neurophysiology, circuit anatomy, and behavior. In
addition, I will receive training and guidance on optogenetic tools in combination with two-photon imaging, and
PFC physiology from Prof. Ofer Yizhar (WI), and computational methods in population activity analysis from Prof.
Mehrdad Jazayeri (MIT). The outlined research, training, and mentorship will facilitate my long-term goal of
establishing an independent researcher leveraging cutting-edge optical technologies available in mice to
understand how PFC feedback modulation optimizes goal-directed sensory processing in the cortex.

Public health relevance
The prefrontal cortex is the part of the brain that hold our cognitive abilities, and it is thought to communicate with our visual system to produce attention towards visual information important for our current needs. In this proposal, we will study the nature of this communication to understand how we choose to attend to discrete aspects of our surroundings. With a thorough understanding of the underlying neuronal mechanisms, we can begin to understand how this communication malfunctions, and attention falls short, in disorders like attention deficit hyperactivity disorder (ADHD) and Schizophrenia.